Planning and Evaluation Core

PROGRAM SUMMARY: PLANNING AND EVALUATION
(This Core is identical for all three Partnering Institutions)
The Partnership between the Morehouse School of Medicine (MSM), Tuskegee University (TU), and the
University of Alabama at Birmingham O’Neal Comprehensive Cancer Center (UAB OCCC) presents a distinct
opportunity to build on our accomplishments in education of future cancer research scientists, with an emphasis
on underrepresented racial/ethnic minorities, and to advance cancer research at all three institutions with a focus
on cancer disparities in the context of a bidirectional engagement with urban and rural communities in Alabama
and Georgia. For this U54 Partnership, evaluation will be conducted by a team of evaluators representing each
partnering institution, who meet monthly to discuss progress, issues, and solutions: Dr. Isabel Scarinci and Ms.
Sylvia Peral (UAB OCCC), Dr. Desiree Rivers (MSM), and Mr. Lecarde Webb (TU). Although they will work
together, each will be primarily responsible for specific Cores and Shared Resources. This team makes
recommendations to be implemented administratively by the Principal Investigators with the advice, guidance,
and direction of each institution’s Executive Committee, the Partnership Leadership Committee (PLC), the
Internal Advisory Committee (IAC), and the Program Steering Committee (PSC). Each Core, Research Project,
and Shared Resource of this Partnership will have its own evaluation plan/worksheet outlining the evaluation
questions for each specific aim, tasks, data collection tools, the person responsible for each task, and timeline.
Process evaluation results will be discussed monthly at the PLC meetings, and comprehensive yearly written
reports will be shared with the IAC and PSC for feedback and guidance. It should be noted that, although each
component will have its own evaluation plan, an integrated evaluation process will be conducted to synergize all
components to achieve the long-term goal of eliminating cancer health disparities.